Phase one clinical trial of a novel small molecule EBNA1 inhibitor, VK-2019, in patients with Epstein- Barr positive nasopharyngeal cancer, with pharmacokinetic and pharmacodynamic correlative studies

Title: Phase one clinical trial of a novel small molecule EBNA1 inhibitor, VK-2019, in patients with Epstein- Barr positive
nasopharyngeal cancer, with pharmacokinetic and pharmacodynamic correlative studies.
7. PROJECT SUMMARY
New therapeutic approaches are needed for cancers associated with Epstein-Barr Virus (EBV). EBV is etiologically
associated with a diverse collection of malignancies, including nasopharyngeal carcinoma (NPC). Only one viral-encoded
protein, EBNA1, is consistently expressed in all known EBV-associated malignancies and is a validated target for inhibition
of EBV-dependent transformation and carcinogenesis.
Investigators at the Wistar Institute have developed VK- 2019, a first-in-class EBNA1 inhibitor as a therapeutic agent,
selecting it from over 2000 candidate inhibitor compounds during the hit-to-lead and lead optimization phases. VK-2019
meets or exceeds industry-accepted criteria for potency, selectivity, metabolic stability, drug suitability, drug safety,
toxicology and bioavailability. VK-2019 inhibits EBNA1 in biochemical assays with nanomolar potency and disrupts EBNA1
binding in vivo in several cell-based assays. VK-2019 causes significant tumor growth protection in 4 different xenograft
models of EBV-driven tumor progression, including 2 tumor lines derived from NPC patients. VK-2019’s in vivo target
engagement and preclinical pharmacokinetic profiles have both been robustly evaluated. Range Finding (RF) and
Maximum Tolerated Dose (MTD) studies in rat and dog have demonstrated an exceptionally favorable safety profile with
a therapeutic index of >87:1. All of the IND-enabling studies including GLP 28-day toxicology and safety pharmacology
studies have been completed. 1.9 kg of cGMP grade VK- 2019 is available and is being formulated into capsules for use
in this study. Wistar staff have held a successful pre-IND meeting with the FDA and are preparing for an IND submission
in April 2018 to facilitate a Phase I first-in-human clinical trial.
The purpose of this grant is to fund the phase 1 clinical trial of VK- 2019 in patients with NPC.
The phase I study will enroll patients with metastatic or recurrent nasopharyngeal carcinoma (NPC) for the following
reasons: 1. Almost all NPC is EBV positive; 2.There is an unmet medical need as current treatments are both toxic and of
limited efficacy. 3. Clinically relevant biomarkers for NPC are available that have relevance for the predicted mechanism
of action of VK-2019. 4. Plasma EBV DNA levels of NPC patients correlate with prognosis and disease progression so can
be used as efficacy biomarkers EBNA1 inhibitors.
The proposed trial is designed to look at the safety and tolerability of VK-2019. A Simon 4b accelerated titration design
of up to 40 patients treated with daily oral VK- 2019 is planned at the Stanford Cancer Institute (SCI), a NCI comprehensive
cancer center and NPC referral center. The primary outcomes will be determination of the pharmacokinetics and
pharmacodynamics of VK-2019, Dose Limiting Toxicity (DLT) and Recommended Phase 2 Dose (RP2D) in patients with
advanced NPC. Important additional endpoints include biomarker and tumor EBNA 1 inhibition effect studies. Clinical trial
infrastructure necessary for the conduct of this study is already in place at the SCI. This clinical trial will provide critical
information on the safety, tolerability and preliminary efficacy of VK-2019 in order to ask whether development of the
agent as a cancer treatment should continue.

Public health relevance
Title: Phase one clinical trial of a novel small molecule EBNA1 inhibitor, VK-2019, in patients with Epstein- Barr positive nasopharyngeal cancer, with pharmacokinetic and pharmacodynamic correlative studies. 8. PROJECT NARRATIVE A safe and efficacious small molecule inhibitor of EBNA1 would change current clinical practice and be valuable for treatment of EBV-associated diseases such as nasopharyngeal carcinoma. Therefore, a novel small molecule inhibitor of EBV with a first-in-class EBNA1 small molecule inhibitor offers the possibility of meaningful anti-cancer effect in NPC patients and at a broader level may direct future research towards the direction of new therapeutics with potentially broad clinical applicability. Success in this proposal would lay the groundwork to provide clinical proof-of-principle for targeting a non-enzymatic DNA-binding proteins, targets previously thought to be “undruggable.”